Race / Ethncicity, Hypertension and Prevention of VCID and Stroke after Intracerebral Hemmorrhage

PROJECT SUMMARY
Intracerebral hemorrhage (ICH) accounts for almost half of stroke-related morbidity and mortality. Among ICH
survivors, nearly 2/3 will develop either incident cognitive decline, in the form of Vascular contributions to
Cognitive Impairment and Dementia (VCID), or recurrent stroke within 5 years. This rapid functional decline,
the result of progression of underlying Cerebral Small Vessel Disease (CSVD), is accelerated for Black and
Hispanic ICH survivors, yielding a substantial health disparity. Arresting this progression therefore holds the
promise of markedly improving outcomes for the >50,000 ICH survivors annually in the US and correcting a
considerable health inequity.
Elevated Blood Pressure (BP) is the most potent predictor of incident VCID and stroke after ICH. Yet >50% of
ICH survivors have untreated hypertension after their ICH, with substantially higher rates among Black and
Hispanic patients. Improving BP control following stroke remains a persistent challenge. Clinical trials of BP
lowering programs have not demonstrated efficacy. A chief obstacle has been a failure to engage patients in the
programs. Social determinants of health (SDOH), the wider set of forces and systems shaping daily life,
contribute to risk for most medical conditions, and are key contributors to race/ethnic health inequities.
Nonetheless, there have been no systematic studies of SDOH in ICH, leaving a crucial gap in knowledge.
The overarching goal of the present renewal proposal, entitled Race / Ethnicity, Hypertension and Prevention
of VCID and Stroke after ICH, is to build on the results of the soon-to-conclude Recurrent Hemorrhagic Stroke
in Minority Populations (R01NS093870) study and fill gaps in the knowledge that is essential for informing the
design of future interventions to enhance BP control and eliminate racial/ethnic inequities in VCID and recurrent
stroke after ICH. The crucial next step is identifying potentially modifiable SDOH that have the highest impact on
1) post-ICH VCID and recurrent stroke; 2) rates of uncontrolled hypertension, and 3) engagement with strategies
to lower BP.
We will enroll and follow longitudinally 700 ICH survivors divided among Black, Hispanic, White, Asian
individuals, all of whom will receive a standardized state-of-the-art evidence-based program of BP management.
We seek to: 1) determine whether modifiable SDOH in association with established biological factors, predict
increased risk for VCID and recurrent stroke after ICH; 2) determine whether modifiable SDOH predict risk of
poor hypertension control after ICH; 3) determine whether modifiable SDOH are associated with decreased
engagement with our standardized BP management program. The data generated will be used to develop novel
strategies for BP management and prevention of VCID and recurrent stroke after ICH, and are likely to have
implications for preventing CSVD-related VCID and stroke, even in those who have not suffered an ICH.

Public health relevance
PROJECT NARRATIVE Spontaneous intracerebral hemorrhage (ICH) results when vessels affected by progressive Cerebral Small Vessel Disease (CSVD) rupture inside the brain. Because CSVD is progressive, ICH survivors, particularly Black and Hispanic survivors, are at high risk for Vascular Cognitive Impairment / Dementia (VCID) and recurrent stroke. Control of hypertension is powerful way to prevent VCID and recurrent stroke, but fewer than half of ICH survivors ever have their hypertension controlled. We will perform a comprehensive assessment of social determinants of health to make crucial discoveries that can be used to help people with ICH control their hypertension, prevent VCID and stroke, and close a substantial health care disparity. Success will add years of quality of life for >50,000 Americans who recover from ICH every year.